Center for Methodologies for Adapting and Personalizing Prevention, Treatment and Recovery Services for SUD and HIV (MAPS Center)

The Center for Methodologies for Adapting and Personalizing Prevention, Treatment, and Recovery Services for SUD and HIV (MAPS Center) will develop, translate, and disseminate novel experimental and data analytic methods to optimize adaptive interventions in substance use disorders (SUD) and HIV services. The overall purpose of the Administrative Core is to oversee all activities of the MAPS Center and ensure the Center as a whole meets the Center-wide overall specific aims. This Core will maintain the MAPS Center’s administrative infrastructure to keep the Center running smoothly; facilitate communication and promote synergy among all MAPS Center investigators, staff, and sites; lift much of the administrative and regulatory burden from investigators; support and facilitate the scientific mission of the Center; and obtain input from well-qualified experts on the Center’s efforts and activities. The Administrative Core will organize and coordinate all research, dissemination, and training activities via three Specific Aims: (Aim 1) To promote productive communication and synergistic collaboration among MAPS Center investigators and between MAPS Center investigators and other SUD/HIV scientists working in prevention, treatment, and recovery services — this includes facilitating innovative center-to-center collaborative partnerships with four well-established, NIH-funded groups that have distinguished records of productivity in behavioral SUD/HIV research; (Aim 2) To enhance the productivity of MAPS Center investigators by facilitating the organization, monitoring, tracking, and reporting of financial and regulatory compliance activities; and (Aim 3) To ensure the MAPS Center becomes a national resource for innovative and high- impact experimental and data analysis methods for adaptive interventions in SUD/HIV prevention, treatment, and recovery services. This Core will work in concert with the Dissemination and Training Core to implement the MAPS Center’s multifaceted dissemination strategy and to ensure that it is effective in its efforts to foster the next generation of SUD/HIV scientists and methodologists equipped to optimize adaptive SUD/HIV services. This Core also will convene meetings of a distinguished external advisory committee to guide the MAPS Center’s scientific mission and activities. The Administrative Core will ensure the MAPS Center operates efficiently, maximizes its productivity, brings new scholars and ideas to the Center and to the field, and fosters continuing methodological improvements to adaptive interventions focused on SUD/HIV prevention, treatment, and recovery services.

Public health relevance
Effective prevention, treatment, and recovery services for substance use disorders (SUD) and HIV and their effective implementation in real-world service settings can be achieved via adaptive interventions; these interventions explicitly guide the modification of the type/intensity of services (or implementation supports) based on the context and changing needs of individuals with or at risk for SUD/HIV and the settings where they receive care. However, (i) existing adaptive intervention approaches have been unable to harness the unprecedented opportunities offered by advances in digital technologies, such as electronic health records (EHRs) and mobile devices; and (ii) existing experimental designs and data analytics have not kept up with the critical questions investigators must address to optimize the adaptation of SUD/HIV services across different levels, modalities, and timescales. The focus of the Methodologies for Adapting and Personalizing Prevention, Treatment, and Recovery Services for SUD and HIV (MAPS Center) is the development, evaluation, and dissemination of novel data collection and data analysis methodologies that are essential to optimize adaptive interventions to combat SUD/HIV. Budgetary Impact There are no budgetary implications associated with these modifications.